Component I: Administrative and Scientific Cores

Component I - Administrative &Scientific Cores Component I of the University of Connecticut's renewal application for an Alcohol Research Center P60 application is designed to assure that all proposed and ongoing research activities within the Center function in a coordinated, efficient and productive fashion (Administrative Core) and that multi-study support facilities and common resources are shared effectively by related projects (Scientific Cores). Component I of the UConn Center's renewal application describes the Center's organizational framework, the authority and roles of the Center's Principal Investigator/ Scientific Director, quality control mechanisms, and the various functions of the Administrative Core. The major functions of the Administrative Core include: budgeting, fiscal planning, resource allocation, scientific enrichment, professional development, facilities improvement, acquisition of new technologies, information management, providing linkages to clinical populations for clinical research, data management and analysis, and access to a biostatistical support. This component also describes the UConn ARC's linkages to several other relevant resources (e.g., GCRC) within the School of Medicine. Also included in Component I are three proposed Scientific Core facilities [biostatistics, clinical research evaluation unit, and a genotyping and analysis facility ] that will contribute to the overall goals of the Center by providing expertise, personnel, laboratory facilities and specialized equipment that are shared by different projects and by serving as training sites for post-doctoral fellows, other alcohol researchers, and visiting scientists. An important part of the UConn ARC's mission is to serve as a local, regional, and national resource for information dissemination, mentoring and scientific consultation, continuing education, and the facilitation of scholarly exchanges. In the proposed grant period, these activities will include sponsorship of continuing education, dissemination of professional education training materials, providing consultation regarding alcohol policy, journal editorial responsibilities, support for visiting foreign scientists, and post-doctoral training.